Binaural Spectral and Temporal Integration with Hearing Loss and Hearing Devices

Project Summary
Approximately 38 million Americans have a hearing impairment. While hearing devices such as hearing
aids (HAs) and cochlear implants (CIs) are successful in improving speech recognition for many hearing-
impaired individuals, there is still significant variability in benefit, and speech recognition in noise remains a
problem. One factor that may limit benefit, especially binaural benefit, is abnormal binaural integration of both
spectral and temporal information.
A prerequisite for binaural integration is binaural fusion — the fusion of stimuli from the two ears into a single
auditory object. Unlike normal-hearing (NH) listeners, we have shown that many HA and CI users experience
abnormally “broad” binaural fusion in the spectral domain, such that pitches that differ greatly in frequency
between the two ears are still heard as a single percept. Individuals with broad fusion also experience abnormal
binaural spectral integration - averaging and thus distortion of spectral information across the ears when
disparate sounds are fused. Broad fusion has been shown to be associated with binaural interference — poorer
speech recognition with two ears compared to one.
Most importantly, we demonstrated recently that broad fusion is associated with greater difficulty with
understanding speech in challenging multi-talker listening situations, such as noisy restaurants. Difficulties with
speech understanding in noise is a major complaint of both HA and CI users. These results demonstrate the
high clinical significance of abnormal binaural fusion for the difficulties that listeners with hearing loss and hearing
devices experience with speech perception in background noise.
However, some gaps remain in our understanding of binaural fusion, especially in individuals with hearing
loss. Do HA and CI users also differ from NH listeners in binaural fusion in the temporal domain, and if so, how
does this affect speech recognition? Another major gap is in how to treat abnormal binaural fusion. There is
unexplored potential for top-down and multi-sensory cues to be used as supplementary cues to help reduce
abnormally broad binaural fusion. Thus, the goal of this proposal is to address these gaps in our understanding
of: 1) how listeners with hearing loss differ from NH listeners in binaural fusion of temporal and spectro-temporal
information (Aim 1), and 2) whether top-down and vibrotactile cues can sharpen binaural fusion, with potential
application for rehabilitation (Aim 2).
The findings will provide broader insights into the neural mechanisms underlying binaural fusion, and
establish a framework for future treatments to sharpen binaural fusion to maximize binaural benefits and improve
speech perception in noise.

Public health relevance
Project Narrative The proposed research will increase our understanding of how hearing loss and hearing devices such as hearing aids and cochlear implants affect binaural processing of information. The results will guide future rehabilitation approaches using device programming or auditory training programs to reduce binaural interference effects and maximize the benefits of bilateral hearing devices for speech perception in quiet and in noise.